Mining the cultured and uncultured biosphere for new drugs

PROJECT SUMMARY/ABSTRACT
This research program focuses on a fundamental barrier in the discovery of new drug molecules from the
environment, known as the supply problem. There is no shortage of new bioactive molecules in the
environment that we can use as drugs, because such molecules have been evolving for billions of years within
trillions of microniches. In this program, we will (1) use both sequence analysis and directed evolution to devise
ways of making promising molecules from uncultured bacteria in laboratory-grown strains, and (2) improve the
discovery rate of new molecules from isolated culturable bacterial strains by determining the shared ways that
their small molecule pathways are regulated, and exploiting that knowledge to turn on these pathways.
1) It is estimated that 1 trillion species of bacteria exist. The number of species that have been grown in the lab
is minuscule by comparison, but that minuscule portion has given us most of the classes of antibiotics currently
known as well as many other drugs. We know that we are missing an incredible amount of chemical diversity in
the uncultured biosphere because we can observe the biosynthetic pathways for small molecules through
culture-independent sequencing. Often these are found in the genomes of bacterial symbionts that live within
another animal, such a marine invertebrate or insect. Currently, this sequence data is simply an academic
curiosity because it is incredibly challenging to move pathways from uncultured symbionts to laboratory strains
which might be separated by more than a billion years of evolution. We will continue to uncover important small
molecule pathways in symbionts, but we will also work towards the supply of these compounds through two
strategies. In the first we will devise new techniques to search for related pathways in the genomes of free-
living bacteria, that might have been previously missed due to incomplete genome assembly. In the second
strategy, we will use evolution to optimize protein sequences for the new host, mimicking how pathways have
been horizontally transferred between different bacteria for billions of years.
2) When bacterial strains are isolated for drug discovery, most of the small molecule pathways they possess
are not expressed under standard culture conditions, and we have to rely on the small subset that are
produced in the lab. This is because most pathways are tightly controlled so that they are expressed under
specific environmental conditions. Many small molecules made by bacteria are thought to inhibit the growth of
rival species, and therefore conditional expression maximizes their impact while reducing the chance that
resistance will develop. While small molecule pathways are passed between species through horizontal
transfer, they become integrated into the pre-existing regulatory network of a new host. We propose to identify
the global regulatory mechanisms for small molecules in a specific group of bacteria, using techniques that are
generalizable, and manipulate them to produce small molecules previously inaccessible in the lab. This will
overcome a major roadblock in drug discovery, allowing the full exploitation of biosynthesis in isolated strains.

Public health relevance
PROJECT NARRATIVE This program aims to develop new ways of both discovering and obtaining evolved small molecules from uncultured and cultured natural sources, so that it is more feasible for them to be developed as drugs. Ultimately, the developed methods will lead to an increase in credible drug candidates from nature, for many indications including (but not limited to) bacterial and fungal infection, and cancer.